NCATS RARE DISEASES ARE NOT RARE 2025 CHALLENGE INITIAL OBLIGATION

NCATS Rare Diseases Are Not Rare! 2025 Challenge Prize Competition:
More than 10,000 known rare diseases affect millions of people across the United States. The Rare Diseases are Not Rare! 2025 Challenge Prize Competition is helping to raise awareness of the importance of rare diseases research and the benefit of identifying solutions to address multiple rare diseases at a time. We welcome creative and original work that can inspire action and shine a light on the rare disease community.